BP-ENDURE: The St. Louis Neuroscience Pipeline

ABSTRACT OF PARENT GRANT
The project abstract is included in the Research Strategy per PA-20-272 guidelines.

Public health relevance
Project Narrative This renewal would continue the tradition of innovative training for top-notch neuroscientists at Washington University. The proposed Neuroscience Pipeline will prepare underrepresented students for graduate-level studies through advanced educational and research experiences, intensive advising and dedicated community outreach. These efforts, combined with our mentor training and evaluation plans, should be scalable and findings translatable to those who share our goals of changing the local culture of mentoring future scientists and increasing diversity in the neurosciences.